Exploration of D-Glucose and D-Mannose Metabolism to Target arenaviruses

PROJECT ABSTRACT/SUMMARY
The viruses belonging to the family Arenaviridae contain several causative agents of hemorrhagic fever in
humans. For instance, Lassa virus causes Lassa fever, which is a major public health threat in endemic regions
of West Africa. Junin virus, Machupo virus, Guanarito virus, Sabia virus, and Chapare virus cause South
American hemorrhagic fevers, severe diseases in humans resulting in high fatality rates. These highly
pathogenic arenaviruses are classified as Risk Group-4 agents, which need to be handled in biosafety level-4
facilities due to their high pathogenicity and lack of vaccines or therapeutics. Additionally, arenaviruses causing
hemorrhagic fevers are listed on Category A Priority Pathogens because of the highest risk to national security
and public health. Thus, countermeasures, such as vaccines or antivirals, against arenavirus infections are
crucial medical needs globally.
Most antiviral agents are inhibitors of proteases or inhibitors of virus replication. In a search for alternative
approaches, we propose to study in more detail the dependence of arenavirus on metabolism of two key
monosaccharides, D-glucose and D-mannose. Our focus will be on using carbohydrate mimetics/antimetabolites
as antivirals. Specifically, we will employ isotopically labeled monosaccharides and molecular probes that
include 2-deoxy-D-glucose (2-DG), a D-glucose, and also a D-mannose analog as a reference compund, and
WP1096, a 2-iodo-D-mannose as a novel prototype carbohydrate antimetabolite antiviral. Our results will
enhance the success of designing future carbohydrate antimetabolite antiviral compounds as therapeutics to
alleviate suffering and contain arenaviral outbreaks.
We will address this goal through three specific aims.
Specific Aim 1. Determine the effect of WP1096 and 2-DG (as a control) on glycolysis pathways and viral
glycoproteins of tissue culture cells infected with arenaviruses (LASV, JUNV and MACV).
Specific Aim 2. In vivo evaluation of WP1096 that includes preclinical toxicology, tissue distribution,
pharmacokinetics, and analysis of active metabolites.
Specific Aim 3. Determine the in vivo protective efficacy of WP1096 and 2-DG (as a control) and analyze
their effects on glycosylation patterns and the host glycolysis pathway.
Taken together, we hope to develop promising pan-arenavirus therapeutics and gain the insight for development
of broad spectrum antivirals effective against multiple viral families.

Public health relevance
PROJECT NARRATIVE Arenaviruses are the causative agents of several viral hemorrhagic fevers; however, there are very limited countermeasures against arenavirus infections, such as vaccines or antiviral drugs, leading to consideration of global threats of pandemics. By targeting the viral glycans with sugar analogs we propose to develop a novel way to treat arenavirus infections. In this project, we will develop the antiviral compounds usable as pan- arenavirus therapy.